Miasano: Mobile Health App for Improved Evidence-Based Rehabilitation Outcomes and Multi-Lingual Clinical Interactions

PROJECT SUMMARY
This SBIR Phase I project will create a proof-of-concept app for improving clinical interactions and use of
evidence-based practice between patients and clinicians who may have different preferred languages. We call
our proposed app Miasano (derived from the phrase “My Health” in the Esperanto Universal Language). The
primary problem that our app addresses is that patient-reported outcome measures (PROMs) are collected
less often in racial/ethnic minorities. Providers may not ask patients to complete PROMs due to language
barriers. For example, the patient would not be able to comprehend a PROM in English and the provider may
not be able to effectively communicate with the patient about the results. Because of the language barrier,
patients may be hesitant or simply unable to express their health concerns or status. Many medical clinics can
offer interpreters to assist with language barriers, but this creates a reliance on interpreter availability. When an
interpreter is present, there is a possibility that the busy interpreter creates unintentional bias when interpreting
PROM questions or relaying provider messages to the patient. These patient populations experience poorer
health outcomes. This leads to health disparities because their health needs are not being properly evaluated
or understood and evidence-based clinical care cannot take place. Further, Miasano provides the opportunity
to be more inclusive in research studies by including PROMs in different languages. Individuals with different
racial/ethnic backgrounds would be more easily included to participate in scientific research that uses PROMs.
Therefore, the disparity in research inclusion would be reduced and could be ultimately eliminated through
better representation in clinical trials and increased applicability of the research results. Our Miasano app
solution to these problems combines several unique features: User Appropriate Language Switching which
allows direct and instantaneous communication of health outcomes and status between two different
languages, providing health assessment in the patient’s preferred language and interpretation of results in the
health care provider’s preferred language, all in the same app; Text-to-Speech Accessibility and use of visual
controls on the mobile device which enhances accessibility to the persons who might have some level of
illiteracy and who prefer to communicate orally. The PROMs queries can be dictated by the mobile device and
the user can respond by tapping on the screen. The health care provider receives the same complete
assessment as if the patient had been able to read; and Defining Medical Terms with pop-up windows that
display common language descriptions is important as medical terms may not be familiar even to those who
are quite literate. The key differentiator of Miasano from current ad hoc clinical methods is empowering the
patient who prefers a language other than English to communicate their health needs and to be confident when
conveying important health information.

Public health relevance
PROJECT NARRATIVE People who have a preferred language other than English for communicating personal things, may experience difficulty when conveying their health status to health care providers who only speak English. We are developing a new app called Miasano for mobile devices, like tablets and smartphones, to help these individuals be heard and receive the same attention in their care regardless of their preferred language. Key features of the Miasano app include validated health assessment methods in multiple languages, the ability for the patient and health care provider to use the app in their own preferred language, and the sharing of important and measurable health outcomes.